Elucidating the Mechanisms Mediating the Impact of Neuroactive Steroids on Network and Behavioral States

Project Summary
Many psychiatric illnesses are characterized by episodes of behavioral disruption. The current project attempts
to understand the mechanisms mediating transitions between healthy and unhealthy brain and behavioral
states. Stress is a major risk factor for psychiatric illnesses and is routinely employed to alter behavioral states
in preclinical models. This application will utilize chronic and postpartum stress to facilitate the transition to the
unhealthy network and behavioral state and investigate the mechanisms mediating these transitions.
Neuroactive steroids (NAS) exert robust anxiolytic and antidepressant effects and a NAS-based treatment,
brexanolone/Zulresso®, recently received FDA approval as the first antidepressant treatment for postpartum
depression. This project will utilize these clinically effective NAS to investigate the impact on network and
behavioral states. Our preliminary data demonstrates that chronic unpredictable stress and inappropriate
postpartum stress can corrupt network activity in the basolateral amygdala (BLA) and that NAS can restore
healthy network and behavioral states. Further, we demonstrate the ability of NAS to alter network activity
across species, including in humans (Conte Center Overview preliminary data), highlighting the translational
relevance of this approach. Despite these provocative preliminary findings, we still lack an understanding of the
mechanisms mediating transitions between network and, therefore, behavioral states. The prolonged
antidepressant effects of allopregnanolone are not easily explained by the known mechanism of action as
positive allosteric modulators (PAMs) at GABAA receptors. In collaboration with our Conte Center collaborators
and the Chemistry Core, we will investigate which of the diverse properties of NAS are capable of restoring
healthy network and behavioral states with the goal of gaining a better understanding of their therapeutic
properties.

Public health relevance
Project Narrative The episodic nature of affective disorders suggests that switching between healthy and unhealthy brain and behavioral states is an inherent feature of some psychiatric illnesses. Neuroactive steroids (NAS) have been implicated in affective switching and have demonstrated persistent antidepressant effects, suggesting the ability to influence behavioral states. The current project will investigate the mechanisms through which NAS can alter network and behavioral states, which will potentially provide insight into the episodic nature of psychiatric illnesses as well as the antidepressant effects of NAS.